Chemical Proteomic Platforms for Radically Expanding Cancer Druggability

PROJECT SUMMARY
Advances in genome sequencing and editing have greatly accelerated the discovery of genes and proteins that
make fundamental contributions to tumorigenesis. Some of these proteins have been targeted by
groundbreaking medicines. Many cancer-relevant proteins, however, lack chemical probes and are even
considered undruggable. In these cases, our understanding of the molecular basis of cancer has not yet
translated into new therapies. The goal of this Outstanding Investigator Award (OIA) renewal application is to
leverage and extend our lab’s innovative activity-based protein profiling (ABPP) technologies to radically
expand the druggable content of the human proteome and develop first-in-class chemical probes for a diverse
array of cancer-relevant proteins. In the previous funding period, we made several fundamental innovations
and advances, including: 1) the introduction of stereochemically defined libraries of electrophilic compounds
(‘stereoprobes’) that accelerate the discovery of cryptic ligandable pockets on cancer-relevant proteins; 2) the
identification and functional characterization of first-in-class covalent ligands for numerous strongly selective
cancer dependency proteins, including historically undruggable transcription factors, RNA-binding proteins,
and adaptors; 3) the discovery of mono- and heterobi-functional ligands that promote the degradation of
cancer-relevant proteins through covalent targeting of E3 ligases and their substrates; and 4) the introduction
of ABPP methods such as paralog hopping for expanding the ligandability of cancer proteomes beyond
covalent chemistry. These achievements have also had a broad impact on cancer therapeutics, where our
ABPP platforms have served as a foundation for the development of several novel drug candidates targeting
selective cancer dependency proteins that are under clinical investigation. In our future research program, we,
along with our extensive set of biology and chemistry collaborators, will continue to lead the field of chemical
proteomics-guided cancer ligand and drug discovery by pursuing innovations that include: 1) novel stereoprobe
library designs to further expand the ligandability of cancer proteomes, including covalent chemistries that
extend beyond cysteine; ii) the development of diverse “function-first” assays for prioritizing covalent ligands
that target cryptic pockets on cancer-relevant proteins; 3) the leveraging of liganding events on DNA/RNA-
binding proteins to create programmable approaches for suppressing pro-tumorigenic transcriptional
processes in cancer cells; and 4) the advancement of ABPP methods to discover ligands that specifically
target cancer-relevant proteoforms of proteins. In summary, with this OIA, we will build on our track-record of
innovation and achievement to realize the ultimate goal of bringing each and every cancer-relevant protein into
the realm of druggability for the benefit of basic and translational research.

Public health relevance
PROJECT NARRATIVE Modern genome sequencing and editing methods have provided remarkable insights into the molecular basis of cancer, but many genetically defined cancer targets lack chemical probes and are even considered undruggable. The goal of this research program is to leverage our lab’s pioneering chemical proteomic technologies to radically expand the druggable content of human cancer cells for the creation of chemical probes and, ultimately, therapeutics for a broad array of human cancer targets.